Topic 412: Wearable Health Informatics Platform for Extensible Research (WHISPER) Phase I

There is an increasing trend toward out-of-clinic research and patient assessment using passive, continuously measured data streams to measure cancer and symptom progression directly and indirectly. This trend has begun incorporating a growing number of wearables beyond fitness trackers, which can provide easy to use measures that are clinically useful. However progress in data acquisition must be accompanied by scalable informatics tools that allow for data aggregation and integration across devices and manufacturers, Population-based statistics will rely on multiple devices to measure context and physiology (e.g., exercise, glucose monitoring, sleep tracking), but integrating them is non-trivial. We propose a wearable informatics tool that satisfies the following technical goals: 1) Ingestion and integration of data acquired from multiple devices and across individuals; 2) Secure, privacy, and HIPAA compliant data transmission, storage, and retrieval; (3) informatics tools for querying, analyzing, and visualizing patient data. Our wearable informatics platform aims to facilitate large scale population studies using wearable technology to promote cancer research and improve health outcomes in cancer populations.